Neural Basis of Stress-Derailed Motherhood

PROJECT SUMMARY
Becoming a mother is often associated with a unique sense of joy, serenity, and personal fulfillment. A
tremendous number of pregnant and postpartum women cannot reach these positive states, though, because
they struggle with high levels of life stress. High pregnancy stress degrades women’s later ability to sensitively
care for their infants, and in very severe cases contributes to infant neglect and abuse. In addition, elevated
stress during pregnancy is one of the most reliable and strongest predictors of maternal depression and
anxiety, which afflict 10-15% of the four million pregnant and recently parturient women in the U.S. each year.
There is a dearth of knowledge about the specific neural mechanisms through which stress contributes to
maternal depression, anxiety, and poor infant caregiving. Without such knowledge, it is virtually impossible to
know how to best intervene or treat women who are at the highest risk. The long-term goal of this line of basic
research is to better understand how stress during pregnancy derails postpartum behavior by affecting
interactions between the stress-signaling neuropeptide, corticotropin releasing factor (CRF), and the
neurotransmitter, serotonin (5-HT). The objective of this R21 exploratory/developmental project is to use a
laboratory rat model of motherhood to begin testing the hypothesis that female reproduction generates
normative changes in CRF receptors in the midbrain dorsal raphe nucleus (i.e., the source of most forebrain 5-
HT), and that these changes are derailed by pregnancy stress. I further hypothesize that the normative
changes across reproduction in CRF receptors in the DR protect mothers against the negative consequences
of stress on their affective and caregiving behaviors. The proposed multi-method research employs a variety of
tools to answer our questions (qRT-PCR, receptor autoradiography, dual-label in situ hybridization, slice
electrophysiology, viral vector-mediated gene up/downregulation, detailed behavior analysis) and is innovative
because it the first to study how stressed and unstressed female reproduction affect CRF receptors site-
specifically in the serotonergic dorsal raphe, and more broadly to provide critical information about the
neurochemistry underlying stress’ impact on the female brain and behavior. This important basic research is
highly significant because our results have the potential to improve strategies for intervention and treatment of
the millions of women and their infants negatively affected by pregnancy stress each year.

Public health relevance
PROJECT NARRATIVE High stress during pregnancy has tremendously negative consequences for women’s ability to sensitively care for their infants, as well as derails maternal mental health. Very little is known about how stress is processed by the maternal brain to cause these negative effects, but it may do so through the stress-signaling molecule, corticotropin releasing factor (CRF), interacting with the brain’s serotonin system. Greater knowledge about CRF-serotonin interactions in the maternal brain will greatly improve our ability to understand the mechanisms underlying peripartum stress, thus helping the millions of mothers struggling to care for their infants and suffering from poor mental health.